Dissect Human Primordial Germ Cell Development Using Stem Cell Models

Project Summary
Primordial germ cells (PGCs), the precursors of eggs and sperm, are essential for human reproduction. A
comprehensive understanding of the molecular mechanisms underlying specification, maturation and migration
of human primordial germ cells (hPGCs) is critical for advancing infertility treatments, regenerative medicine,
and potential therapies for genetic disorders. Most of our current knowledge on mammalian germline biology is
derived from studies using laboratory mice. However, due to the unique transcriptional networks and
developmental pathways of hPGCs, the knowledge from other species cannot be directly extrapolated.
Moreover, PGCs emerge during the earliest stage of embryogenesis, undergoing complex morphogenesis and
migration, which presents significant technical challenges for in vivo tracking and study.
The overarching objective of my research is to develop stem cell-based modeling systems that closely
recapitulate the landmarks of human embryonic developmental processes, and to apply these systems to
elucidate the fundamental mechanisms governing human development. Notably, over the past few years, I
developed a stem cell-based microfluidic human embryoid model that faithfully recapitulates the early
development of human embryonic sac in a highly controllable and scalable fashion, wherein the emergence of
hPGCs mirrors the molecular signatures and developmental trajectories observed in vivo. I also recently
devised a novel method for deriving hPGC-like cells (hPGCLCs) using an embryonic-like culture system. This
method significantly simplifies hPGCLC induction protocols and provides insights into how the native cellular
microenvironment facilitates hPGC specification.
The research objectives for this five-year project are to integrate approaches from developmental and
stem cell biology, microengineering, genome editing, and bioinformatics to uncover the fundamental
mechanisms driving early hPGC specification and migration. Specifically, 1) leveraging the microfluidic
embryoid platform, we will generate a novel lineage reporter line to perform lineage tracing assays on
hPGCLCs. Through single-cell RNA sequencing and functional genetic studies, we aim to elucidate the origin
and lineage trajectory of hPGCs. 2) We will establish a PGC-hindgut co-development model to investigate the
maturation and migration of hPGCs after specification. We anticipate this model will yield insights into the
mechanisms governing hPGC migration and the cellular crosstalk between hPGCs and the hindgut. 3) Using
the embryoid and PGC-hindgut co-development models, we will systematically dissect the roles of Wnt
signaling in hPGC lineage commitment and migration. Successful completion of this project will deepen our
knowledge of human germline biology and facilitate future research on hereditary diseases and reproductive
medicine.

Public health relevance
Project Narrative The emergence and development of human primordial germ cells (hPGCs), the precursors of human egg and sperm cells, are crucial for human reproduction, but remain poorly understood due to interspecies differences and lack of suitable experimental models. In this proposed research, we will employ innovative stem cell- derived models to investigate the molecular and cellular mechanisms governing hPGC specification, maturation and migration. The successful completion of this project will provide critical insights, which are essential for advancing our understanding of hereditary diseases and enhancing reproductive medicine.